Pathobiology and Clinical Profile of HIV-Associated Cancers in India and the West

DESCRIPTION (provided by applicant): With the widespread availability of antiretroviral therapy (ART), cancer has emerged as a leading cause of mortality in people living with human immunodeficiency virus (HIV) infection. This is well documented in the US and Europe and we propose to study this trend in India. Lymphomas as well as head and neck cancers are the most common gender- independent cancers seen in the HIV-positive population at TATA Memorial Hospital in Mumbai, India. We propose to study both head and neck cancer, and lymphomas in molecular terms. This project will strengthen pre-existing collaborations between TATA Memorial Hospital, which is the largest public cancer hospital in India, and the University of North Carolina NCI-designated Lineberger Comprehensive Cancer Center.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application seeks to characterize HIV/AIDS related cancers in molecular and clinical terms as seen at TATA memorial hospital in Mumbai, India. It will establish an US-India collaboration centered on common studies in AIDS related lymphoma and head and neck cancer in HIV+ patients.